Innovating next generation technologies to define mechanisms of neurodegenerative disease and devise therapeutic strategies

Project Summary/Abstract:
This is a proposal to consolidate our NINDS research projects into one larger R35 award, enabling us
the time and flexibility to explore important biological questions relevant to human neurodegenerative diseases.
My laboratory has used a combination of yeast and human genetics to define novel mechanisms of ALS, FTD,
and Parkinson’s disease. These experiments have led to the discovery of ataxin 2 intermediate-length
polyglutamine expansions as a major genetic risk factor for ALS. We found that reduction of ataxin 2 in mouse
profoundly extends survival of TDP-43 transgenic mice (either by genetic knockout or using ASOs). These
preclinical studies have led to the initiation of a clinical trial in human to test ataxin 2 ASOs in human ALS. We
have pursued ataxin 2 as a therapeutic target in ALS and have identified additional regulators of ataxin 2 levels
including a small molecule that can lower ataxin 2 levels in vitro and in vivo. Given the success of these
genetic screens for finding regulators of ataxin 2 levels, I propose performing genomewide modifier screens in
human cells using CRISPR/Cas9 for regulators of additional neurodegenerative disease proteins. We recently
identified dozens of cryptic splicing events that occur in neurons harboring TDP-43 pathology, including one in
the UNC13A gene, one of the strongest GWAS hits for FTD/ALS. Importantly, we found that the genetic
variations in UNC13A that increase risk for disease increase cryptic exon inclusion in the face of TDP-43
pathology. We propose functional studies to elucidate the role of additional cryptic splicing targets in ALS
pathogenesis. Finally, we have expanded efforts to include single-cell sequencing and have performed RNA-
sequencing on adult mouse spinal cord, revealing remarkable heterogeneity and new markers of skeletal
motor neuron subtypes. We propose studies to apply this technology to mouse models of ALS and to human
spinal cord. Together, we present an ambitious research program aimed at defining novel mechanisms of
human neurodegenerative diseases and then intensely working to translate those mechanisms to novel
therapies to help treat these devastating conditions.

Public health relevance
Project Narrative Amyotrophic lateral sclerosis (ALS) and other neurodegenerative diseases are devastating for individuals and families involved; there are no cures and few treatments. Our studies have revealed new insights into the major ALS protein TDP-43, defined a new genetic risk factor for ALS – mutations in the ataxin 2 gene, validated it as a therapeutic target, and discovered that cryptic splicing in the UNC13A gene explains why variants in this gene increase risk for ALS. The proposed studies will use genomewide approaches to reveal regulators and therapeutic targets to lower neurodegenerative disease proteins, single-cell transcriptomics to define mechanisms of motor neuron degeneration, and exploring additional TDP-43 cryptic splicing targets, laying the foundation for the development of novel therapeutic approaches.